Platelet function abnormalities underlying bleeding in a connective tissue disorder the Ehlers Danlos syndrome

Summary
Ehlers-Danlos syndrome (EDS) is a heterogeneous group of hereditary connective tissue disorders
characterized by disorganized extracellular matrix due to defects in collagen fibrillogenesis. Bleeding is a
common problem in patients with EDS. Recently, we showed that EDS carries a high risk of hemorrhagic
complications, including bleeding after surgery and tooth extraction, which were severe or life-threatening
in nearly 42% of EDS patients. Currently, no approved protocols or guidelines exist to prevent or treat
bleeding in EDS patients, which may result in treatment delays, especially in emergencies. The long-term
objective of this proposal is to prevent hemorrhage and improve the outcome of the bleeding diathesis in
patients with EDS. A few studies have identified platelet function abnormalities in EDS patients, but none
have examined the mechanistic relationship between impaired platelet function and bleeding risk. In pilot
studies, we found that platelets from EDS patients exhibit reduced baseline GPVI expression associated
with decreased agonist-induced platelet aggregation and impaired integrin αIIbβ3 activation. We further
found that a mouse model of the classical type of EDS recapitulates EDS patients' platelet and bleeding
phenotypes. Using human samples and murine models, we propose to further define the underlying
mechanisms linking impaired platelet function and the bleeding diathesis in EDS. In Aim 1, we will
characterize the mechanism of impaired platelet function in vitro using patient and EDS mouse samples.
In Aim 2, we will determine whether the impaired platelet function and hemostasis abnormalities are due to
an intrinsic defect in platelets or an effect of the abnormal ECM environment. In Aim 3, we will test novel
interventions to restore hemostasis in a murine model of EDS. A strength of the proposal is that we will
use both clinical samples and preclinical models of EDS to define mechanisms in vitro and in vivo and to
test interventions to restore hemostasis. Our team has extensive collaborative expertise, which will
increase the feasibility and the likelihood of success. The overall impact of the proposed research is high
because it will provide novel insights into platelet receptor characteristics and scientific knowledge
regarding the underlying mechanisms of impaired platelet function and risk of bleeding in EDS. The study
results are anticipated to raise awareness of the role of platelet function testing for appropriate evaluation
and treatment of EDS patients with a high risk of bleeding, particularly prior to invasive procedures or
surgery.

Public health relevance
Project Narrative Bleeding is a common clinical problem in patients with Ehlers–Danlos syndrome (EDS), yet there are currently no approved guidelines for preventing or managing hemorrhagic complications. Platelet function abnormalities have been reported in EDS patients, but the mechanisms remain unclear. A definitive understanding of why platelets are less reactive in EDS patients has important pathophysiological significance and potential clinical application to diagnostic approaches in patients with connective tissue disorders.